Sex Differences in Cardiac Macrophages in Response to Pulmonary Hypertension

Project Abstract
Pulmonary arterial hypertension (PAH) is a progressive and incurable disease with high
morbidity and mortality. Although PAH is significantly more prevalent in women compared to
men, female PAH patients exhibit better right ventricular (RV) function and survival. However,
the mechanisms underlying superior female adaptation to RV pressure overload in PAH remain
unknown. This proposal seeks to identify the role of RV macrophages in mediating sexual
dimorphisms in RV function in PAH. This investigation is motivated by our compelling recently
published data demonstrating that macrophages play a role in RV maladaptive remodeling in
experimental pulmonary hypertension (PH) through effects the extracellular matrix (ECM), and
that removal of macrophages in PH results in decreased collagens and other ECM proteins,
improving RV contractility and RV-pulmonary arterial (RV-PA) coupling. Furthermore, through
single cell RNA sequencing experiments of cells from the murine RVs, we discovered profound
sexual dimorphism in gene expression in resident cardiac macrophages from male and female
mice that include upregulation of several genes involved in ECM organization and collagen
binding in males. We have previously shown that endogenous and exogenous 17beta-estradiol
(E2) improves RV function in ovariectomized females and in males with PH, that E2 decreases
collagen accumulation in the RV, and that E2 down-regulates the pro-inflammatory and pro-
fibrotic transcriptome of bone marrow-derived macrophages. We now seek to understand
whether the sexual dimorphisms we identified in RV adaptation and cardiac macrophage
function are explained in part by transcriptional effects of sex hormones on the pro-fibrotic
programming of RV macrophages. We hypothesize that female sex hormones regulate
expression of RV macrophage genes associated with fibroblast activation and ECM
stiffness, resulting in sexual dimorphisms in RV contractility, stiffness, and diastolic
dysfunction in adaptation to RV pressure overload. Specifically, we hypothesize that female
hormones downregulate pro-fibrotic programming in resident RV macrophages, resulting in less
fibroblast activation and ECM stiffening. We will utilize the experimental PH models of mouse
pulmonary artery banding and rat Sugen hypoxia, and examine differences in resident RV
macrophage gene expression, RV contractility and stiffness, and the RV ECM between healthy
and diseased male and female animals. We will utilize a menopausal animal model and
exogenous estradiol hormone replacement therapy to examine how female and male sex
hormones regulate RV macrophage programming.

Public health relevance
Project Narrative Pulmonary arterial hypertension is a rare disease with high mortality affecting predominantly women. However, men who develop pulmonary hypertension have higher rates of right heart failure and death than women. We seek to understand the biologic reasons for the protection of right heart function in women by studying sex differences in the function of immune cells of the heart, in hopes that this will lead to new treatments to improve right heart function in pulmonary hypertension patients.